Investigating Informal Caregivers' Involvement in End-of-Life Care among Assisted Living Residents with Advanced Dementia and its Influence on Resident and Caregiver Outcomes

PROJECT SUMMARY/ABSTRACT
The public health burden of Alzheimer's disease and related dementias (AD/ADRD) continues to increase as
the American population ages. We are becoming increasingly aware of myriad physical and emotional needs
confronted by people with dementia and their informal caregivers (unpaid family and friends) particularly at end
of life (EOL). Most persons with AD/ADRD in the U.S. die in long-term care (LTC) communities, and assisted
living (AL), as the fastest growing LTC option in the U.S., is a primary provider of this care. AL is a social model
of care and in most states does not provide 24-hour skilled nursing care; most care is provided by unlicensed
direct care workers with little or no healthcare training. Therefore, residents' informal caregivers play a critical
role in supplementing this care. Their involvement ranges from social visits to more intensive types of informal
care provision, including hands-on-care and monitoring and managing care that AL staff and other formal care
providers (e.g., hospice) provide. What effect such involvement has on the health of informal caregivers and
their care recipients over time is unknown. Limited empirical evidence from cross-sectional and retrospective
research shows that greater informal caregiver involvement, particularly involvement that is more labor
intensive and emotionally taxing, is associated with higher caregiver burden and suggests that this burden may
be greater for informal caregivers in AL compared with other LTC settings, particularly in the context of caring
for residents with advanced dementia at EOL. Some studies show that lower informal caregiver involvement is
associated with lower resident quality of life of residents but these relationships have not been investigated in
AL in depth or over time and the direction of these effects is unclear. To address these critical knowledge gaps,
we propose a prospective longitudinal multilevel study that will follow 280 residents diagnosed with advanced
AD/ADRD (6 or higher on the 7-stage dementia scale) for 12 months and assess the caregiving experiences of
residents' primary informal caregivers (n=280). We will select residents and their informal caregivers from a
stratified random sample of 45 assisted living communities in Georgia. The overall goal of this 5-year study is
to improve understanding of the relationships between and among informal caregiver involvement, informal
caregiver health (e.g., perceived physical and mental health, caregiver burden, and distress), and quality of life
of assisted living residents with advanced dementia at EOL and to identify potentially modifiable factors at
multiple socioecological levels (individual, AL, and wider community-level) associated with adverse outcomes.
The proposed study supports the National Alzheimer's plan and its mission to improve care and support of
persons with AD/ADRD and their caregivers. It will address significant knowledge gaps that will advance
science and provide information vital to guide policy and practice, including recommendations for training and
education for staff and families, and inform future intervention trials designed to improve EOL dementia care.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE This 5-year multilevel longitudinal study investigates informal caregivers' (unpaid family members and friends) involvement in end-of-life care of residents with advanced dementia in 45 diverse assisted living communities in Georgia. Our goal is to improve understanding of the relationships between and among informal caregiver involvement, informal caregiver health, and quality of life of assisted living residents with advanced dementia at end of life and ultimately identify potentially modifiable factors at the individual, assisted living, and wider community-level associated with adverse outcomes. This study, which is the first to focus on these relationships in depth or over time, will offer valuable insights to researchers, policymakers, and providers.